Circulating Biomarkers for the Detection of Human Liver Diseases

Hepatocellular Carcinoma (HCC) is the third most common cause of cancer-related deaths worldwide. The risk
of liver fibrosis and HCC increases significantly in hepatitis C virus (HCV) carriers with obesity and diabetes,
which is a rising trend in the USA. Thus, HCC represents a wide-ranging public health issue. Our recent
studies have revealed a positive correlation between overexpression of doublecortin-like kinase (DCLK1) and
cancers of the liver, colon, intestine and pancreas. Recently, we have demonstrated that increased expression
of DCLK1 in patients with cirrhosis and HCC. Furthermore, we demonstrated that DCLK1 expression tends to
increase during progression of liver diseases such as cirrhosis and HCC. Downregulation of DCLK1 resulted in
marked reduction of HCC cell proliferation and tumor-like growth in immunodeficient mice. Our studies indicate
that DCLK1-affected biological processes in the pancreas and colon cancers including epithelial-to-
mesenchymal transition (EMT) and cMYC pathways. For example, knockdown of DCLK1 results in marked
upregulation of tumor-suppressor miRNAs (let-7a, miR-200, miR-144, and miR-145/143) with a concomitant
decrease in cMYC, ZEB1/ZEB2, KRAS, NOTCH1, VEGFR1 and 2, and pluripotency factors OCT4, SOX2,
NANOG and KLF4. Thus, DCLK1 appears to be a well-justified targets for anti-tumor treatment and is a
potential prognostic biomarker for detecting/identifying/differentiating various stages of cirrhosis (based on
Child-Pugh Score A – C) and HCC. Furthermore, several miRNAs (miR-21, miR-199a, and miR-301) are
upregulated in cirrhosis and HCC, correlated with diseases outcomes. Furthermore these miRNAs are known
to regulate/induce EMT and oncogenesis. Based on these observations, we hypothesize that DCLK1 and
miRNAs are upregulated and can be detected in plasma of patients with HCC, and can be a biomarker
for the detection of cirrhosis and HCC. The expression of DCLK1 and miRNAs will be compared to
AFP-L3 levels in patients with fibrosis, cirrhosis and HCC. Here we will collect blood from 4 groups of
patients – healthy controls, patients with fibrosis (but non-cirrhotic and non-HCC; classified based on
FIB4 scoring), cirrhosis (non-HCC; Child-Pugh A – C) and HCC (either Child A, B or C). Samples will
be collected at OKC VAMC (test cohort) and also at VA St. Louis Health Care System (validation
cohort). We will test the hypothesis with the following specific aims. Aim 1. Identify candidate miRNAs-
regulating EMT in the blood stream of patients with liver fibrosis or HCC. We will isolate total miRNAs
from the plasma (collected from clinically defined fibrosis, cirrhosis and HCC) and perform microarray analysis
to identify various miRNAs upregulated that have been associated with the regulation of EMT, in patients with
liver diseases. We will also determine expression of specific miRNAs regulated by DCLK1. Aim 2. Determine
whether plasma levels of DCLK1 are associated with the development of HCC. We will employ enzyme-
linked immunosorbent assay (ELISA) (commercially available) to detect DCLK1 in patients' plasma (fibrosis,
various stages of cirrhosis and HCC). We will also determine whether DCLK1 is increased in patients with
cirrhosis and/or HCC compared to healthy controls. We will also estimate the plasma AFP-L3 levels in all the
study subjects and compare it with DCLK1 and miRNA levels. Aim 3. To determine the signaling pathways
that regulate EMT and metastasis, and stemness of circulating tumor cells isolated from HCC patients.
Here we will isolate circulating cancer cells (from HCC patients) and determine their EMT signature, DCLK1
and miRNA status, and their clogenicity, migration and invasion capabilities. Successful completion of these
studies will provide a new direction to combat HCC at an early stage. As 78% of the VA patients with liver
diseases are diagnosed with HCC (median survival of 4.5–9.2 months), early detection of HCC by our methods
will help the VA clinicians to decide early treatment strategies to increase the survival of the veterans.

Public health relevance
Cirrhosis and HCC is the most common type liver diseases in the US, and is second only to lung and colorectal cancer incident in the VA population. Thus the burden of illness from HCC is substantial for the veterans. VA is the largest provider of liver disease care in the US. In the recent years, a 5-fold increase in the incidence of liver diseases among veteran was observed and 78% of these cases are diagnosed with HCC with a survival of only 4.5 – 9.2 months. The magnitude of such low survival rate is quite concerning. This project will develop non-invasive and clinically acceptable methods of detection of early cirrhosis and HCC using the patients' blood. This will be an enormous step towards the early diagnosis of HCC and will help the VA physicians to decide early treatment strategy to prevent the progression of pre-cancerous condition to cancer among the veteran population.